Signaling networks and transcriptional programs in lens vesicle formation

PROJECT SUMMARY /ABSTRACT
Anterior segment dysgenesis (ASD) refers to a spectrum of disorders that affect the front of the eye, including
the corneal, iris/ciliary body, and lens. Among the characterized ASD genes, the majority encode transcription
factors. However, the upstream signaling events that control these transcription factors are unclear. My long-
term goal is to establish the gene regulatory networks that underlies the development of the anterior segment of
the eye, in order to identify molecular targets for disease prevention and treatment. The objective of this proposal
is to study signaling networks and transcriptional programs in lens development. In particular, I have identified
mechanistic target of rapamycin complex 1 (mTORC1) signaling as a novel regulator in lens vesicle formation.
And I propose to investigate both the upstream regulators and the downstream targets of mTORC1, using a
combination of conditional knockout mouse and primary lens epithelium cell models. My central hypothesis is
that Fibroblast Growth Factor (FGF) signaling activates mTORC1 in the lens epithelium (Aim 1), and this
mTORC1 signaling controls cell adherence during lens vesicle formation through regulating Wnt signaling (Aim
2). In Aim 1, I will elucidate the mechanism underlying how FGF signaling activates mTORC1 in the lens
epithelium. In Aim 2, I will investigate how mTORC1 regulates Wnt signaling and the functional significance of
mTORC1-Wnt axis in the formation of adherens junctions in the lens epithelium. In addition, I propose to identify
mTORC1 mediated transcriptional programs during lens vesicle formation by Single-cell RNA-sequencing. This
proposal is innovative because it identifies a novel regulatory pathway in lens vesicle development. It also links
signaling pathways and transcriptional factors to elucidate the mechanism of lens vesicle development and
disease pathogenesis. Results from this study are significant in that they are expected to impact the
understanding of normal and defective development of the lens vesicle, and have the potential to reveal novel
molecular targets for preventive purpose of disease caused by congenital lens defects.
The mentored phase of this project will be conducted under the guidance of Drs. Xin Zhang and Carol Mason
(Columbia University Irving Medical Center), who are experts in eye development and signaling pathways.
Additional advice will be obtained from my scientific advisor Dr. Melinda Duncan and Dr. Peter Sims on aspect
of lens development and Single cell RNA-sequencing, respectively. Resources for career development along
with the research environment at Columbia University are ideal for my transition into an independent investigator
studying signaling mechanisms of eye development and disease.

Public health relevance
PROJECT NARRATIVE Defective lens development causes multiple congenital eye diseases. This project aims to understand the mechanisms underlying normal development and disease conditions of the lens. This research will have the potential to reveal novel targets for preventative medicine.